Administrative Core

PROJECT SUMMARY/ABSTRACT
The members of the NYNORC constitute a diverse and productive group of 115 scientists who study obesity
and nutrition across two campuses. Their current research is supported by $132M (direct funds per annum) of
which $60M annually are obesity and nutrition-focused, representing 206 grants. They have published 289
manuscripts on obesity/nutrition during the current funding period and in 2019-2020 obtained 105 new or
renewed NIH grants. The mission of the NYNORC is to build and provide physical and intellectual infrastructure
that supports its members in their efforts to study obesity and nutrition. The Administrative Core (AC) leads and
coordinates these efforts by overseeing the Center’s three scientific cores, by advocating on behalf of the
NYNORC’s scientists, by cultivating and supporting new obesity researchers, collaborations and research
directions, and by ensuring that the NYNORC meets its commitments to our members, our parent institutions,
the NIH and our wider community. To achieve our goals we have implemented administrative strategies: (1) To
cultivate and promote obesity-focused research at Einstein and Columbia (2) To build and support an evolving
scientific infrastructure for obesity research (3) To advocate and represent NYNORC members to our institutions
and supporters (4) To fulfill the NYNORC’s commitments to our membership, our parent universities, the NIH
and broader obesity research community (5) To support clinical and translational work of the NYNORC scientists.